Validation of artificial intelligence (AI) based software as medical device (SaMD) for retinopathy of prematurity (ROP)

The purpose of this application is to perform the necessary clinical studies to seek regulatory approval for an
artificial intelligence (AI) software as medical device (SaMD) for retinopathy of prematurity (ROP) diagnosis.
ROP is a leading cause of childhood blindness worldwide, with approximately 50,000 babies going blind
annually, most of which is preventable with accurate and timely diagnosis. The i-ROP DL algorithm was
developed by the i-ROP research consortium and has been shown to provide expert-level diagnosis of plus
disease, a component of severe ROP, based on images from the Retcam (Natus, Middleton, WI) digital fundus
camera. The output is a vascular severity score (VSS) that corresponds to spectrum of plus disease, as defined
by the International Classification of ROP, and has been endorsed by the Food & Drug Administration (FDA) as
an appropriate output for an ROP SaMD. If incorporated into a clinical workflow, this technology could provide
automated, immediate, expert-level diagnosis of ROP to the bedside, solving one of the key gaps in care that
results in preventable blindness worldwide. The first aim of this project is to update and retrain the i-ROP DL
algorithm to improve speed and repeatability for clinical use, finalize the image quality and pre-processing
pipeline, and integrate it into the iTeleGEN data management system, an ROP telemedicine software platform.
The second aim is to perform the necessary clinical studies for the two proposed indications for use (IFU): The
first IFU will be as an assistive diagnostic study to improve the clinical diagnosis of plus disease with regulatory
approval based on a multi-reader multi-case study with a primary outcome of improved diagnosis of plus disease,
based on a five expert reference standard diagnosis, with the use of the VSS. The second IFU will be for
autonomous ROP screening for more than mild ROP (MTMROP, defined as type 2 or worse according to the
Early Treatment for ROP study definition). The pivotal study will have a primary outcome of 85% sensitivity and
85% specificity for the diagnosis of MTMROP, with a secondary outcome of greater than 95% sensitivity for
detection of treatment-requiring ROP. The third aim of the proposal is to validate the i-ROP DL algorithm on a
digital fundus camera made by Forus Health (Bengaluru, India), a digital eye care company, with ROP camera
distribution in more than 20 countries. If successful, then once FDA approval is obtained on the Retcam it may
be extended through a 510K process to a camera that is more affordable than the Retcam and widely available
in low- and middle-income countries. This work will be done by Siloam Vision, a company started by two of the
inventors of the i-ROP DL algorithm, in conjunction with Oregon Health & Science University. At the end of the
study period, the goal will be to have the necessary data to support FDA approval of the i-ROP DL algorithm for
two IFUs on two digital fundus cameras and being one step closer to bringing this technology to the bedside to
reduce the number of babies going blind from ROP worldwide.

Public health relevance
Retinopathy of prematurity (ROP) is a leading cause of childhood blindness, which is most often preventable when accurate and timely ROP diagnosis can be provided. Artificial intelligence (AI) has the potential to provide immediate, expert-level clinical diagnosis to medical images, such as digital fundus images taken as part of ROP screening in neonatal care units. In this application, Siloam Vision will perform the necessary steps required to seek regulatory approval for the first AI algorithm for ROP diagnosis, which is the first step in making this technology available worldwide and potentially reducing the number of children who go blind from ROP.